A Mixed Methods Evaluation of Developing COPD Exacerbations in the MARC Cohort

Project Summary/Abstract
Acute exacerbations of chronic obstructive pulmonary disease (COPD) increase the morbidity and
mortality of the disease and are the major drivers of its high healthcare costs. Early treatment of exacerbations
with systemic corticosteroids and/or antibiotics has been shown to mitigate many of their negative effects.
However, prior efforts to detect exacerbations early enough to facilitate outpatient management have
demonstrated mixed results. Electronic monitoring, in which patients are remotely monitored for changes in
their clinical status, is a promising approach to detect exacerbations prior to presentation to care, facilitate
earlier connection to outpatient management, and prevent progression to hospitalization. Electronic inhaler
monitors can be attached to short-acting beta agonist (SABA) inhalers to record each actuation and transmit
that data to the healthcare team. Because patients are instructed to respond to worsening symptoms by
increasing use of their SABA inhalers, electronic inhaler monitors which detect this increase in use may be a
potential tool to identify clinical worsening. However, there has been little research examining the use of
electronic inhaler monitors in the early stages of a COPD exacerbation.
To address this knowledge gap, we will conduct a secondary data analysis of an existing cohort of
>250 patients with COPD enrolled into the Medication Adherence Research in COPD Patients (MARC R01 HL
128620: PI Eakin) study. As part of the MARC study, participants are monitored with weekly electronic
symptom logs, electronic inhaler monitors, and monthly phone calls collecting information on recent
exacerbations for a 12-month monitoring period. In Specific Aim 1, we will leverage this data to demonstrate
that SABA use increases as respiratory symptoms worsen and then examine whether these increases in SABA
use are associated with increased odds of a moderate or severe exacerbation. Because prior research
suggests that not all patients with worsening symptoms increase their SABA use as instructed, in Specific Aim
2 we will evaluate whether patient-level risk factors, such as low cognitive functioning, are associated with this
type of poor self-management. In Specific Aim 3, we will conduct a qualitative study using semi-structured
interviews guided by the framework of Self-Regulation Theory to explore participants’ thought processes
around their self-management during periods of worsening symptoms. This research will therefore not only
evaluate the associations among respiratory symptoms, SABA use, and exacerbations but also seeks to shed
light on patient subgroups that struggle to effectively self-manage their worsening symptoms.
This proposal will provide the applicant with the necessary training to develop the quantitative and
qualitative skills needed to pursue an independent career as a health services researcher in COPD.

Public health relevance
Project Narrative Despite evidence that early treatment of chronic obstructive pulmonary disease (COPD) exacerbations improves outcomes, prior efforts to identify exacerbations prior to presentation to care have demonstrated mixed results. Because patients are instructed to increase their use of short-acting beta agonist (SABA) inhalers in response to worsening symptoms, electronic inhaler monitors that detect these increases may be used to identify exacerbations earlier in their course, expedite outpatient management, and decrease the risk for hospitalization. In this study, we will examine whether SABA inhaler use is associated with respiratory symptoms and exacerbations, examine possible risk factors for poor self-management, and conduct a qualitative study to explore participants’ thought processes surrounding their self-management.